Informal Social Network Dyads and Comorbid Problem Drinking and PTSD in Rape Victims

Purpose of the administrative supplement The purpose of this administrative supplement request is to support the effort needed to fulfill the NIMH Data Archiving (NDA) requirement associated with our current Ro1. The specific activities associated with the NDA requirements are included in the Data Sharing and Archiving Plan attached to this supplement request application. The New NDA requirement places a significant burden on our study’s budget. This was not included in the original grant budget as we were unaware of the new requirement so we did not include it in our original study budget. In addition, our requested budget was cut by 10%. Given this, we are requesting a small amount additional funds to help us stay on track with this new NDA data submission requirement. We utilized the NIH calculator spreadsheet to determine how much we may need in additional funding (see attached budget). We appreciate your consideration of this request to ensure the success of our study and our ability to meet the new NDA requirements.

Public health relevance
Project Narrative Rape is a major public health issue affecting 20% of American women in their lifetimes and costing billions of dollars each year due to deleterious outcomes (e.g., problem drinking, depression, poor physical health) associated with these experiences. This proposed study examines the social support rape victims receive from specific members of their informal social networks to learn how to intervene to improve assault-specific social support to (a) reduce associated outcomes of PTSD, depression, and problem drinking and substance use for victims of both alcohol-related and non-alcohol-related rapes; (b) reduce secondary traumatic stress for informal support providers; and (c) improve relationships between victims and their informal support network members. The project is relevant to the NIAAA’s mission in targeting social networks in a high- risk population and studying dyadic processes in relation to victims’ problem drinking and psychological symptoms in order to develop community-based interventions.